Complement in the Pathogenesis of Autoimmune Arthritis

[unreadable] DESCRIPTION (provided by applicant): [unreadable] The innate immune system is centrally important to the development of collagen-induced arthritis (CIA), a widely studied model for the human disease rheumatoid arthritis (RA). Complement is a key component of the innate immune system, and complement activation in inflamed joints has been previously shown to both characterize active disease in patients with RA as well as to be essential to the development of CIA in mice and other similar animal models. There is little understanding, though, of the specific mechanisms by which complement influences cellular and humoral autoimmunity in CIA, or how complement activation fragments intersect with other innate immune mechanisms in the disease process. This proposal addresses three key issues relative to the roles of complement in the evolution of CIA, each with therapeutic implications. The first is the role of the alternative pathway of complement, which is arguably among the most evolutionarily ancient members of this system, in disease pathogenesis. The second is the role of complement at the interface of innate and adaptive immunity in disease, as manifest by functions of complement receptors 2 (CR2/CD21) and 1 (CR1/CD35). These receptors are highly expressed on B cells as well as follicular dendritic cells (FDC), and recent studies by the PI and his collaborators have strongly suggested that interruption of CR2/CR1 function results in a marked decrease in the generation of tissue injury in models of tissue-specific autoimmunity. In addition, B cells are increasingly recognized as key cell types in the development of rheumatoid arthritis in humans, and non-depleting mAbs that target the essential B ceil receptor (BCR) co-receptor complex that includes CR2 and CD19 may also be an effective therapy in the absence of B cell depletion. The third issue that will be evaluated is the relative contribution to the development of joint injury of serum-derived, as compared to infiltrating immune cell-derived, complement factors. These studies will build upon an emerging understanding of the key role of local complement production in tissue injury and immune responses. We propose the following specific aims: Specific Aim #1: Determine the role of the alternative pathway of complement in the development of joint inflammation and injury in CIA. Specific Aim #2: Experimentally manipulate the expression and function of the B cell co-receptor signal transduction complex containing complement receptors CR2/CR1 and CD19 in CIA in order to identify and characterize the specific roles played by complement receptors in the modulation of autoimmunity and tissue injury. [unreadable] [unreadable]